Data Science Core

BEAMS ABSTRACT: Core D
The Data Science Core (Core D) will provide expertise in data management and integration, statistics,
bioinformatics, and computing to all projects and cores in this Program Project Grant (PPG). Core D is
composed of quantitative scientists with extensive experience in pediatric asthma cohort studies, data
management and integration, and the development and application of novel analysis methods for microbiome,
RNA-Seq, and other omics technologies. Core D will provide coordinated statistical study design and analysis
to all projects, statistical learning and informatics functionality for omics studies, and an integrated data
management platform, that supports project goals and facilitates investigator access to multi-project integrated
data sets and custom analysis tools. Core D data scientists make extensive use of modern methods of statistical
computing and reproducible research tools. This capability fosters the sharing of analysis code and results, the
rapid deployment of novel analysis tools, and effective investigator access to program-wide data and knowledge
management platforms for cross-project research discovery. Core D is a vital component of each project in this
PPG. Core D will facilitate the discovery of novel scientific results describing how prenatal and early life
environmental exposures shape gut microbial colonization and immune system development, and confer an
asthma-protective effect.